Admin Core

Summary
The primary goal of the Administrative Core is to provide logistical, organizational, and managerial support for
this Biomarker Characterization Center (BCC) and foster the interaction of the BCC with the other EDRN team
members and Centers, including BCCs, CVCs, the DMCC, and the NCI. As current BDL and BRL grantees from
JHU, we will build on the effective communication and coordination strategies in place to form an integrated BCC
that works effectively with all EDRN Centers and aligned with NCI goals and priorities. We will have a strong
base of support from the experienced investigators and an internal framework to ensure integrated operations
of the BDL and BRL components, adherence to project and network milestones and timelines, and overall project
success. We will work to ensure the success of the entire EDRN program and will participate in the EDRN
Steering Committee, and EDRN meetings and teleconferences. The Administrative Core will collaborate,
interact, and ensure bidirectional exchange of findings and insights with the other EDRN BCC, CVC, and DMCC
team members. We will also provide resources and support for the validation of biomarkers developed by the
EDRN, and ensure participation in collaborative projects with other laboratories and centers. In summary, we
will leverage the robust leadership structure and collaborative-team work experience of the proposed BCC to
facilitate realization of the overall goals of the EDRN and ensure the success of the BDL and BRL.